How Do Synaptonemal Complex Proteins Promote Crossover Recombination and Synapsis?

Project Summary
Our proposed research aims to decipher the molecular mechanisms that underlie homologous chromosome
segregation during reproductive cell formation. Meiosis is the specialized cell division cycle that partitions the
two homologous copies of every chromosome (homologs) to separate daughter nuclei, effectively reducing
chromosome ploidy. Errors in chromosome segregation lead to aneuploid reproductive cells that carry too
many or two few chromosomes. Key to the success of homolog segregation is the prior establishment of
transient but stable associations between replicated chromosomes; for most organisms these links are formed
by interhomolog crossover recombination events, in conjunction with intact sister cohesion.
How crossover events are efficiently generated between every chromosome pair during meiosis remains
poorly understood, but for most organisms it is clear that the process involves an exquisite coordination
between large-scale chromosome movements and local DNA repair processes. A conserved multi-protein
structure, the synaptonemal complex (SC), mediates an intimate alignment between homologous partner
chromosome axes and forms the physical context in which DNA repair intermediates mature. SC has long
been associated with successful crossover recombination, and although our recent research demonstrated that
the SC structure per se is dispensable for crossing over in budding yeast, we also showed that the SC building
block component, Zip1, has a genetically separable function in promoting crossovers. Our structure-function
analysis revealed adjacent domains within Zip1’s N terminus that function independently to promote crossover
recombination and SC assembly, potentially through separately interfacing with the pro-crossover E3 SUMO
ligase, Zip3, and the SC central element protein complex Ecm11-Gmc2.
Our recent data has i) revealed a potential phosphorylation-based switch in Zip1’s N terminus that controls
its crossover activity, ii) identified several regions within the Zip3 protein required for its pro-recombination
and/or pro-SC assembly activities, iii) narrowed the minimal interaction interface between Ecm11 and Gmc2,
and iv) demonstrated proximity labeling interactions between pro-crossover proteins (and possibly SC central
element proteins) that are stabilized by Zip1’s N terminus. Our proposed experiments, which are designed to
support a uniquely rich training environment for several undergraduates, a new “5th year” Masters student, and
one doctoral student, build upon our recent experimental data and aim to deepen our structural and functional
understanding of the molecular mechanisms that coordinate recombination and SC assembly in S. cerevisiae.

Public health relevance
Narrative Over 10% of clinically recognized human pregnancies are aneuploid, a result of errors in homologous chromosome (homolog) segregation during meiosis. Homolog segregation relies on the prior establishment of pair-wise associations between partner chromosomes, which facilitate their proper orientation and subsequent disjunction toward opposite spindle poles. A prominent meiotic chromosomal structure, the synaptonemal complex (SC), facilitates large-scale chromosome reorganization and collaborates with recombination factors to promote local DNA exchange events; our research proposal seeks to define key structural features of SC proteins and molecular mechanisms that promote DNA exchange during meiosis, and that coordinate recombination with SC assembly along the length of aligned homolog pairs.